Contract Orientation & Kick Off Meeting in support of IDIQ "Preclinical Pharmacokinetic and Pharmacology Evaluations of Agents Being Developed for Cancer Patients." R&D Services

Contract Orientation and Kickoff Meeting in support of IDIQ Preclinical Pharmacokinetic and Pharmacology Evaluations of Agents Being Developed for Cancer Patients